High-resolution genomic mapping of ssDNA and associated proteins for Alzheimer's disease research

PROJECT SUMMARY
EpiCypher is collaborating with Dr. Jessica Tyler (an expert in aging, DNA repair and epigenetics), to
develop CUT&RUssNTM (Cleavage Under Targets and Release Using single-stranded Nuclease), a first-in-class
single-stranded DNA (ssDNA) mapping technology for research into the early pathogenesis of and possible
interventions for Alzheimer’s Disease (AD). The double-stranded conformation of genomic DNA (dsDNA) is
essential to maintain genome stability. ssDNA forms during many cellular processes, including transcription and
the processing of DNA lesions, and is rapidly sequestered by ssDNA binding proteins (SSBs) (e.g. RPA, RAD51
and BRCA1/BRCA2) to protect and facilitate any needed repair. AD is the most common form of
neurodegeneration, with early pathogenesis / neuronal cell death due in part to the accumulation of DNA damage
as a consequence of defective repair mechanisms (particularly homologous recombination [HR], which is heavily
reliant on ssDNA signaling pathways). Improved methods for detecting and mapping ssDNA and SSB-ssDNA
complexes that accompany DNA damage repair would greatly improve our understanding of how failure of these
pathways contributes to AD, and potentially reveal novel drug targets and biomarkers. However, tools to study
ssDNA-related signaling are lacking. The first innovation of our approach is the development of a novel
immunotethering approach, wherein: 1) an antibody to an ssDNA-associated feature (e.g. SSB) is used to locally
tether an ssDNA-specific nuclease to chromatin in permeabilized nuclei; 2) next, the nuclease is activated to
selectively cleave nearby ssDNA and not dsDNA; and 3) cleaved fragments are collected and sequenced to
yield a precise ssDNA target localization profile. The development of protein A/G (pAG) fused to an ssDNA-
specific nuclease is a key innovation, as it enables the definitive identification of ssDNA associated with any
localizing factor. A second innovation of our approach is the development of nucleosome spike-in controls
containing either ssDNA or dsDNA, which will be used: 1) to confirm nuclease specificity; and 2) to enable
quantitative comparisons in disease / control samples -/+ eventual drug treatment. The goals of this Phase I
project are to develop the CUT&RUssN workflow (Aim 1) and demonstrate its ability to map SSB-ssDNA
complexes in cells, thus enabling the novel study of ssDNA repair pathways in AD models (Aim 2). In Phase II,
we will expand the CUT&RUssN platform to additional chromatin features (e.g. SSBs or histone PTMs) and their
associated cellular mechanisms (e.g. transcription, R-loops, DNA replication). In addition, we will develop robust
protocols for widely studied AD models and human post-mortem brains, including low cell input applications and
assay automation to enable large-scale clinical studies. At the end of Phase II, we will launch a CUT&RUssN
beta-kit and assay services, which will be marketed to researchers, drug developers, and clinicians to accelerate
AD drug discovery.

Public health relevance
PROJECT NARRATIVE Single-stranded DNA (ssDNA) forms during many cellular processes, including transcription and DNA damage repair, and is rapidly bound by ssDNA binding proteins to facilitate these processes. Alzheimer’s disease (AD) is caused in part by the accumulation of DNA damage in neurons, with early pathogenesis a consequence of defective DNA repair. Improved methods for mapping the localization of ssDNA and its association with ssDNA binding complexes would greatly improve our understanding of AD pathology, potentially also revealing novel drug targets and/or biomarkers. Here, EpiCypher is collaborating with Dr. Jessica Tyler (an expert in aging, DNA repair and epigenetics) to develop CUT&RUssNTM (Cleavage Under Targets and Release Using single-stranded Nuclease), a first-in-class genomic mapping technology to quantitatively map ssDNA for AD research and drug development.